MONITORING OF HIV 1 INFECTED SUBJECTS AFTER WITHDRAWAL OF ANTIRETROVIRAL THERAPY

The goal of this study is to determine whether individuals treated within 90 days of the onset of symptoms of HIV infection and suppressed with antiretroviral therapy for a period of two to three years can control the residual virus activity when the drugs are voluntarily withdrawn.